Mechanisms of iron-mediated renal injury in lupus nephritis

PROJECT SUMMARY/ABSTRACT
Lupus is a chronic, often debilitating autoimmune disease that predominantly affects young women. Damage to
the kidneys (lupus nephritis) is a serious and common complication of lupus, affecting approximately 50% of
patients, and has been linked with poor patient prognosis and increased risk of premature death. Current
treatments for lupus are based on suppressing the immune system and inflammation. Unfortunately, these
treatments, which include corticosteroids, have serious side effects and in many patients do not adequately
protect the kidneys, highlighting the need for new treatment approaches. Iron is an important component of the
body, but when present in excess can cause damage to cells. Evidence suggests that iron metabolism may be
abnormal in the kidneys of lupus patients, with a growing body of literature indicating that several iron
metabolism proteins can serve as urinary biomarkers of lupus nephritis. Our published report demonstrates
that iron accumulation is increased in the kidneys and that reducing body iron levels helps to protect the
kidneys from developing injury in a mouse model of lupus nephritis. This proposal investigates the
mechanisms by which iron promotes kidney injury in lupus, with our goal being to specifically block these
damaging effects while maintaining normal iron homeostasis. Specifically, we propose that in lupus nephritis,
enhanced filtration of iron sources, including transferrin, leads to glomerular and tubular injury including iron-
induced cell death (ferroptosis), contributing to the progression of kidney injury in lupus nephritis. Ferroptosis is
a recently described form of cell death and has never been studied or targeted in lupus. Our preliminary data
show that one of the key mediators of ferroptosis, the enzyme acyl-CoA synthetase long chain family member
4 (ACSL4), is dramatically upregulated in glomeruli and renal tubules around the onset of albuminuria in mice
with lupus, with further increases evident as injury progresses. We will conduct experiments in genetic and
inducible mouse models of lupus nephritis to test the role of iron and ACSL4 in promoting both glomerular and
tubular injury in lupus nephritis, and whether drugs targeting iron accumulation or players in the ferroptotic
pathway can stop further progression of renal injury. Together, these experiments will provide important novel
insights into the disease mechanisms underlying the progression of renal injury in lupus, and offer potential
new therapeutic approaches to treating lupus nephritis.

Public health relevance
PROJECT NARRATIVE Systemic lupus erythematosus (or lupus) is a chronic, often debilitating autoimmune disease that attacks a number of parts of the body. Damage to the kidneys (lupus nephritis) is a serious and common complication of lupus, affecting approximately 50% of patients, and current treatments are only partially effective and have serious side effects. Our proposal focuses on novel mechanisms of kidney injury in lupus: iron-induced inflammation, fibrosis and cell death (ferroptosis). Our studies will help us better understand a novel mechanism of renal injury in lupus, and whether blocking these processes could serve as a new or complementary treatment strategy for lupus nephritis.